ANNUAL SYMPOSIUM

Our World Wide Web Home Page provides a description of our research emphasis on carbon isotopomer analysis and intracellular cations; available "products" with brief descriptions of tcaSIM, tcaCALC, TmDOTP5-, and our 3 day training course, as well as who to contact to obtain more information about these items; the annual symposium announcement with the program, speakers, symposium site, and registration information; a list of the Facility's personnel, users, and contacts; and a few representative publications. Our Home Page is at URL http//www.swmed.edu/home_pages/rogersmr. Our World-Wide Web access statistics indicate an average of more than 300 connects each month from non-UT Southwestern client domains. Since September 1, 1997, some of the countries that have requested files from our Web site include Austria, Australia, Brazil, Canada, Chile, Croatia, Denmark, Egypt, Finland, France, Germany, Greece, Iceland, India, Ireland, Israel, Italy, Japan, Mexico, Netherlands, Norway, Portugal, Russian Federation, Singapore, South Africa, Sweden, Switzerland, Taiwan, Turkey, United Arab Emirates, United Kingdom, and Yugoslavia.